Clinical and Translational Core (Core C)

PROJECT SUMMARY TO CLINICAL AND TRANSLATION CORE
Kidney diseases predispose affected individuals to high rates of end stage renal disease (ESRD),
cardiovascular disease (CVD) and premature death. With nearly 30 million Americans estimated to have
chronic kidney disease, the healthcare costs are tremendous. Identification of novel mechanisms for the
pathogenesis of kidney diseases and related complications is urgently needed to improve adverse clinical
outcomes and to reduce the financial burden on the US healthcare system. The George M. O'Brien Kidney
Research Core Center at Northwestern University (NU-GoKIDNEY) will promote and support research
into the discovery of novel therapeutics that will transform the prevention and treatment of kidney
diseases and eventually lead to cures. The Center will join basic and clinical investigators to conduct
translational research focused on the discovery of novel therapeutic modalities for patients with
kidney diseases. Research catalyzed by the Preclinical Models Core and the Therapeutics Development
Core will lead to discoveries of novel therapies, which will be translated into patients through the activities of
the Clinical and Translational Core. The Core Leaders will work together to synergistically advance the
Center’s chief goal of finding new treatments that will improve the lives of patients with kidney diseases. The
Clinical and Translational Core will provide a centralized environment, essential resources and multi-
disciplinary expertise to safely and ethically translate and target the discoveries identified by the Preclinical
Model and Therapeutics Development Cores into the right patient population. We will efficiently connect
investigators with: (1) the most appropriate components of the existing clinical research infrastructure; (2)
relevant analytic experts; (3) well-matched talent in methods not commonly used in nephrology research, (4)
unique data and biosample repositories; and (5) community-based research study participants and leaders in
bioethics and medical humanities. Our goals are: (1) to enhance the integration of institutional strengths in
clinical research; (2) to encourage cross-disciplinary collaboration within and between the Cores; (3) to
introduce new disciplines into the field of kidney diseases research; (4) to improve the ability of investigators to
phenotype participants through access to data and biosample repositories; and (5) to enrich the experience of
study participants by enlisting involvement of bioethicists, study participants and community providers in the
development of research protocols. By leveraging our strong institutional environment, existing resources and
multidisciplinary expertise, the Clinical and Translational Core will accelerate the translation of preclinical
discoveries into meaningful health improvements for patients with kidney diseases.